Microenterprise and Behavioral Economics Intervention for Sexual and Biomedical HIV Prevention in Vulnerable U.S. Young Adults

Project Summary / Abstract
Economic vulnerability and racial disparities contribute to African-American young adults being
disproportionately infected by HIV. African-Americans account for nearly half of all HIV diagnoses in the U.S.,
and young adults have the highest HIV rates of all U.S. age groups, comprising an increasing proportion of the
urban poor. Economic instability, such as homelessness and unemployment, is associated with higher HIV
prevalence. Experiencing economic instability can create imperatives to engage in survival strategies that
increase HIV risk and diminish motivations to avoid HIV, resulting in sexual risk-taking and low uptake of
preventive medications. Microenterprise interventions (i.e., very small businesses) have improved sexual
behaviors and medication adherence in low-income countries by combining HIV prevention and business
training, mentoring, and grants – primarily in women. Microenterprise reduces HIV risk through increased
economic stability via jobs and employable income-generating skills. This, in turn, decreases financial distress
associated with risk behaviors, while increasing resources to access HIV services and improving non-cognitive
skills (i.e., persistence, grit) associated with healthy behaviors. However, microenterprise studies have largely
been omitted in men and African-Americans with limited longitudinal assessment. Prior studies have also not
leveraged mobile health or behavioral economics (BE) to shape how youth perceive prevention costs and
rewards. Having obtained promising preliminary data from our completed K01 that demonstrated feasibility and
acceptability of a microenterprise pilot, the proposed R01 builds on the K01 by establishing efficacy on two
important HIV behavioral and biomedical primary outcomes: condomless sex and movement along the pre-
exposure prophylaxis (PrEP) continuum (i.e., contemplation, clinic appointment, initiation), and on intermediate
and mediating variables related to economic stability. We will implement a peer-driven microenterprise model,
adapted for underserved U.S. communities. Our interdisciplinary team has expertise in prevention science,
sexual health, microfinance, epidemiology, biostatistics, qualitative science, and behavioral economics. We will
randomize participants to experimental group that will receive entrepreneurial, financial literacy, and HIV
prevention education (i.e., condom use, PrEP), microgrants, mentors, text messages informed by BE, and job
announcements or to control group that will receive usual care job announcements. We will use respondent-
driven sampling to recruit high-risk, economically-vulnerable, HIV-uninfected seeds and their peers, aged 18-
24. To leverage peer support, we will randomize by cluster, equal to a seed and their recruits. The specific
aims are to: (1) Evaluate the efficacy of the intervention on economic stability, condomless sex, and PrEP
initiation up to 24-months post-intervention; (2) Assess heterogeneity of intervention effects; and (3) Examine
mechanisms of change using statistical and qualitative methods. If found to be effective, the intervention has
the potential to be a model of HIV risk reduction and economic empowerment in U.S. urban settings.

Public health relevance
PROJECT NARRATIVE Economic vulnerability and racial disparities contribute to African-American young adults being disproportionately infected by HIV. The proposed intervention applies a peer-driven microenterprise model adapted for underserved U.S. communities and integrating text messages informed by behavioral economics to test the efficacy and mediating and differential effects on the reduction of condomless sex and increase in uptake of pre-exposure prophylaxis in high-risk, economically-vulnerable African-American young adults. Microenterprise reduces HIV risk through increased economic stability via jobs and employable income- generating skills that is hypothesized, in turn, to decrease financial distress associated with high-risk behaviors, while increasing resources to access HIV services.